PANCREAS &ISLET TRANSPLANTATION IN HUMANS

The overall goal of the work described in this proposal is to increase our understanding of the metabolic consequences of successful pancreas and islet transplantation in Type I diabetic patients, and to ascertain the long-term metabolic consequences of hemi-pancreatectomy in healthy human donors. Special emphasis will be given to our long term follow-up of recipients of successful pancreas transplantation and of hemi-pancreatectomized donors.